Vasopressin Signaling in Pain and Alcohol Dependence

Project Summary ______
Alcohol use disorder (AUD) is associated with the emergence of negative emotional states that can influence
the motivational properties of alcohol. Pain represents one such motivational state hypothesized to drive AUD
severity (Egli, Koob, and Edwards, 2012), and this relationship is particularly concerning since there are limited
treatments for either chronic pain or AUD. Ascending nociceptive circuitry and excessive alcohol exposure
alters the function of central brain stress and reinforcement systems, including the central amygdala (CeA).
Related neuroadaptations may underlie negative reinforcement mechanisms driven by persistent pain in the
context of AUD. We have discovered the emergence of a significant mechanical and thermal nociceptive
hypersensitivity (or hyperalgesia) in alcohol-dependent male rats and our current aim is to interrogate valid
animal models of excessive drinking and hyperalgesia toward the elucidation of neuropharmacological
mechanisms contributing to these conditions in alcohol dependence. Our previous work implicated the stress
neuropeptide vasopressin in the transition to dependence in male rats via its actions on V1b receptors (V1bRs;
Edwards et al., 2012). While V1bR antagonists reduce excessive drinking in rodents and facilitate abstinence
in alcohol-dependent individuals (Ryan et al., 2016), additional evidence suggests that they may also reduce
stress-induced hyperalgesia (Bradesi et al., 2009). Pain-related affective responses are also enhanced via
vasopressin signaling through CeA V1a receptors (V1aRs, Cragg et al., 2016), although the contribution of this
receptor system to excessive drinking or hyperalgesia in the context of alcohol dependence is unexplored. As
two key stress-regulatory systems, vasopressin and glucocorticoid signaling may closely interact, with each
system driving the other's activity in a bidirectional fashion. Elucidation of this link could be critical to
understanding the efficacy of glucocorticoid receptor antagonist therapy in reducing excessive drinking in
preclinical and clinical models (Vendruscolo et al., 2015). Our primary hypothesis is that blockade of either of
two subclasses of central vasopressin receptors (V1bRs or V1aRs) in a key pain- and reinforcement-related
brain area (CeA) will reduce both excessive drinking and hyperalgesia in alcohol-dependent animals. Our
secondary hypothesis is that blockade of vasopressin V1bR signaling will reduce GR phosphorylation in the
CeA of alcohol-dependent animals, while blockade of GR transcription activity will also reduce vasopressin
system gene expression in the CeA. We also propose an investigation of sex as a factor in these relationships
given the substantial human sex differences in alcohol withdrawal and pain. A better understanding of the
central brain mechanisms of alcohol dependence-related behaviors (excessive drinking and hyperalgesia) will
provide substantial insight into neurobiological mechanisms of dependence and may reveal novel treatment
opportunities for AUD and persistent pain in the context of AUD.

Public health relevance
Project Narrative ______ Men and women suffering from severe alcohol use disorder (AUD) can experience symptoms of pain that may promote further heavy drinking in attempts to alleviate the pain. Our proposal aims to understand brain mechanisms of these conditions and develop new medication strategies that effectively treat both excessive drinking and persistent pain using an animal model of severe AUD.